Role of HIV Envelope Proteins In Viral Replication and HIV Pathogenesis

In the past year we demonstrated that MAdCAM and retinoic acid (RA), two constituents of gut tissues, together with TGF-beta, promote the differentiation of CD4+ T cells into alpha4beta7+CD69+CD103+ cells consistent with TRMs. These cells also express CCR5 and CCR9. CCR5 renders these cells susceptible to HIV infection, despite the anti-proliferative action of TGF-beta. Formation of TRMs was reduced by MAdCAM antagonists developed to treat inflammatory bowel diseases. Of note, CD4+ tissue resident memory T cells (TRMs) are implicated in the formation of persistent HIV reservoirs that are established in the very early stages of infection. The tissue-specific factors that direct T cells to establish tissue residency are not well defined, as is the case for the factors that establish viral latency. Our findings help explain the contribution of CD4+ TRMs to persistent viral reservoirs and HIV pathogenesis.